Understanding the Mechanisms of Respiratory Supercomplexes and mitochondrial Complex I

PROJECT SUMMARY/ABSTRACT
The mitochondrial oxidative phosphorylation electron transport chain (ETC) is composed of five large
membrane protein complexes (CI, CII, CIII2, CIV and CV) and is responsible for the production of the majority
of cellular adenosine triphosphate (ATP). Consequently, in humans the ETC is essential to bioenergetic
metabolism. ETC defects are one of the most commonly diagnosed congenital metabolic defects, with CI
deficiencies representing roughly a third of these diagnoses. Although ~50% of patients with CI deficiencies die
within the first 2 years of life and only ~25% reach 10 years of age, there are currently no effective treatments
for CI or other ETC deficiencies. This discrepancy stems in part from an incomplete understanding of the
molecular mechanisms of the individual complexes and their higher-order assemblies into supercomplexes
(SCs). In mammalian heart mitochondria the majority of CI is found in association with CIII2 and CIV (SC
I+III2+IV, the respirasome) or in association with CIII2 (SC I+III2). Despite recent advances in our mechanistic
understanding of the ETC complexes brought about by biochemical and structural work, significant questions
remain regarding the function, mechanism and regulation of the complexes and SCs. To address these gaps in
our understanding and to develop the basic science that will underpin potential treatment strategies of ETC
defects, we will pursue three major research directions in my lab. Using detailed biochemical and enzymatic
analyses together with cryo-electron microscopy structural characterizations, we will 1) elucidate the molecular
mechanism and regulation of respiratory CI; 2) understand the physiological role respiratory SCs play in health
and disease; and 3) characterize the biodiversity of the core metabolic respiratory pathway. To achieve this,
we propose to perform systematic functional and structural comparisons of respiratory chains from mammalian
mitochondria, the model invertebrate Drosophila melanogaster, the fungal model system Ustilago maydis, the
planktonic protist Diplonema papillatum and the a-proteobacteria Paracoccus denitrificans. Further we will
characterize respiratory complex and SC structure and function from mouse models of mitochondrial disease.
Comparing respiratory metabolism from these divergent and genetically tractable organisms will allow us to
test several key mechanistic hypotheses and identify conserved and divergent features of regulation. This will
provide deep insights into biological energy-conserving mechanisms, which will define the scientific foundation
needed for the development of therapeutic strategies against CI and further ETC deficiencies.

Public health relevance
PROJECT NARRATIVE The mitochondrial electron transport chain (ETC) is an essential metabolic pathway in humans, and its disfunction causes debilitating and fatal diseases with no current treatments. The goal of this proposal is to understand, at the atomic level, the mechanism and regulation of mitochondrial ETC complexes and supercomplexes in native-like conditions. Defining how the enzymes function and can be regulated in diverse contexts will provide the basic science foundation for future strategies in drug development and treatment of metabolic disease.